Achieving Diversity through Integrative Scientific Research Experience (ADISRE)

“Achieving Diversity through Integrative Scientific Research Experience” (ADISRE) is a new
student-centered NIBIB-ESTEEMED research education program. ADISRE is about “Creating A
Desire” for learning and the ethical and useful application of scientific thought and method. The over-
arching goal is to produce STEM graduates with an internal drive to serve their community by pursuing
a career in biomedical sciences. This program will expand, leverage and improve upon a previously
successful research education model (NIBIB-EDEPS) conducted at Savannah State University by A)
expanding the number of high-achieving student participants from 13 to 28; B) Increasing the
emphasis on doctoral careers in the biomedical sciences through the nature of training activities,
including a holistic 6-week summer bridge program; C) Enhance the ability of ADISRE scholars to gain
entrance into competitive doctoral programs through rigorous and interactive training, negating the
need for them to garner post baccalaureate experience; and D) Create a broad, long-term institutional
impact of integrative teaching and learning through the development of a new team taught Core Area-
D science laboratory course for freshmen and sophomores. The ADISRE program will nurture
creativity, promote teamwork, ethical conduct, scientific rigor, proper documentation, innovation and
product development.

Public health relevance
“Achieving Diversity through Integrative Scientific Research Experience” (ADISRE) is a new student- centered NIBIB-ESTEEMED research education program about “Creating A Desire” for learning and the ethical and useful application of scientific thought and method. The over-arching goal is to produce STEM graduates with an internal drive to serve their community by pursuing a career in biomedical sciences.